Automating Viral Genome Annotation and Quality Control for Viruses of Public Health Importance

Abstract
National Center of Biotechnology (NCBI) and International Nucleotide Sequence Database Collaboration
(INSDC) databases have been cornerstones of public sharing of pathogen genomic data for basic science and
epidemiological investigations. To ensure the integrity of sequence databases, all sequences must be
validated and curated prior to deposition into GenBank. A major bottleneck in the rapid sharing of viral
sequencing data is the requirement for inclusion of gene and/or protein annotations along with curation of
sequences prior to deposition to NCBI GenBank. Annotations are critical for cross-referencing other NCBI
databases, while curation is required to ensure the accuracy and usability of the databases. However, correctly
annotating and performing appropriate quality control can be challenging to non-specialist submitters. Notably,
this limitation is restricted to viral sequences, as prokaryotic and eukaryotic genome annotation and quality
control has been automated via the NCBI's Prokaryotic and Eukaryotic Genome Annotation Pipelines.
Recently, NCBI has created an open-source viral annotation tool called VADR (Viral Annotation DefineR).
VADR validates and annotates viral sequences using RefSeq-based models. VADR is currently limited to a
select number of human viruses, including SARS-CoV-2, influenza virus, monkeypox virus, norovirus, dengue
virus, and respiratory syncytial virus. The implementation of VADR has reduced manual reviews by NCBI
indexers by >95% for these viruses, illustrating its critical role in prescreening submitted viral sequences.
However, for most viruses relevant to clinical infectious diseases and public health, there is no way to rapidly
submit unannotated consensus sequences to open databases. Here, we propose to accelerate the public
sharing of viral sequences by building, validating, and implementing sustainable, open-source VADR models
for human viruses relevant to public health. Specifically, we will build, validate, and implement appropriate
open-source models for VADR for respiratory viruses, viruses associated with vaccine preventable diseases,
and hepatitis viruses, taking advantage of the moderate numbers of viral sequences available for these
viruses. Our group has significant knowledge of viral genome quality control, annotation, and submission,
including their associated challenges as currently constructed in NCBI. Using viral genome data from other
sequencing projects, we will validate the accuracy and sustainability of our newly generated VADR models on
sequences not yet present in NCBI GenBank. Working together with NCBI, we will deploy these open-source
models to automate analysis for GenBank by the end of the grant period. The proposed work will both ease
submission and increase open genomic data for viruses of public health importance. This work will and ensure
that we are ready for increasing amounts of routine public health sequencing and help overall preparedness for
the next pandemic.
1

Public health relevance
Project Narrative Public sharing of viral genomic data is critical for developing vaccines, therapeutics, and diagnostics and realizing the potential of real-time genomic epidemiology. However, submission of viral consensus sequences to fully public databases is currently automated for only six viral species. Here, we propose to extend an open source viral genome annotation tool (VADR) to significantly more viruses of public health importance to enable widespread viral genomic data sharing and prepare for the next pandemic.